Georgia Department of Agriculture's Laboratory Flexible Funding Model project

Laboratory Flexible Funding Model (LFFM) - OVERALL
Project Period: July 1, 2020 to June 30, 2025
Project Summary / Abstract (Overall)
The Manufactured Food Regulatory Program Standards (MFRPS) and Animal Feed Regulatory
Program Standards (AFRPS) established a uniform foundation for management of state
programs responsible for the regulation of facilities including laboratory analysis for chemical
and microbiological contaminants. The Georgia Department of Agriculture (GDA) participated in
a 2011 Improvement Plan followed by a five-year cooperative agreement to obtain ISO/IEC
17025 Accreditation. This project was later supported by a two-year Accreditation Maintenance
and Enhancement grant and an addition year to expand upon accreditation in order to support
the regulatory agency’s primary servicing lab. GDA laboratories achieved, enhanced, and
maintained accreditation which assists their regulatory agencies in compliance requirements for
contractual work on behalf of FDA.
In order for GDA laboratories to maintain their accreditation and support the regulatory agency
as their primary laboratory, continuous support is needed to offset the added expense required
for Quality Assurance activities as well as the ongoing upkeep of critical analytical equipment.
For state partners to accept added responsibility for Global Food Safety initiatives continued
support and enhancement will be necessary for the primary servicing labs to maintain analytical
capability for meeting these goals. To achieve these goals the laboratory will rely upon
established relationships with our regulatory agency and their agreement to collect and analyze
samples under the MFRPS and AFRPS agreements for possible regulatory enforcement. GDA
has already developed and demonstrated successful relationships with their regulatory partners
and ability to fulfill this objective. Signed agreements have been previously forged to collect and
analyzed samples for contaminants using state inspectors and robust sampling plans. These
results will be submitted in a national database repository and violative adulterations will be
subject to appropriate regulatory action. This grant will allow GDA laboratories to maintain
accreditation to international standards, protect the public by collecting and analyzing samples
for contaminants and to cumulatively contribute to an integrated national food safety system.

Public health relevance
Overall Component: Project Narrative Project Period: July 1, 2020 – June 30, 2025 Project Narrative Georgia Department of Agriculture (GDA) will continue to strive toward full compliance with the Manufactured Food Regulatory Program Standards (MFRPS) and Animal Feed Regulatory Program Standards (AFRPS) by building capacity in an integrated food safety program consisting of combined contributions from state, local, and federal collaborators. This project will ensure that samples are analyzed by primary servicing laboratories using quality systems to give regulatory partners assurance in in test results and their enforcement response. This grant will leverage state resources and capabilities to further advance the Food Safety Modernization Act and an Integrated Food Safety System